Workshops on Genomics and Next Generation Computational Statistics for Big Data

ABSTRACT
The future challenges of genomic science are enormous. Data sets continue to grow; with high-throughput
technologies, and Biobank datasets, studies with105 cases and107 markers will soon be commonplace.
Electronic health record (EHR) datasets are also rapidly expanding. Health data will soon be routinely collected
from mobile and wearable devices, dramatically increasing their volume and utility. This data is critically important
for advancing the understanding of human diversity and disease. Precision health and predictive medicine raise
the stakes even further. It is imperative that all genomic researchers in the 21st century have a command of the
quantitative and computational Big Data tools necessary for genomic research at this scale.
The goal of this program is to provide training in next generation mathematical and statistical theory and
computational methods for genomics and Big Data analysis. The program is designed for (1) researchers at the
postdoctoral and early career level; (2) more senior biomedical researchers transitioning to more quantitative
genomic research, with the goal of acquiring new research skills or updating existing knowledge; and (3) more
senior computational scientists who wish to apply their methods in a new domain, and gain contacts among
researchers active in those fields. Our program is useful for those trainee researchers whose career focus is
computational methods development, but will also be useful for those researchers who want to add a genomics
methods development component to their research program.
We propose to create a one-week workshop on genomics and next generation computational statistics for Big
Data to be held on the campus of the University of California, Los Angeles. The week will include a program of
lectures, tutorials, hands-on teaching labs and exercises, and project-based one-on-one sessions with Program
Faculty genomic scientists. The participants will be provided with 1) training in statistical and mathematical
genomics theory; 2) training in the use of statistical and computational methods and tools to analyze genomic
data; 3) training in computational methods development; 4) exposure to cutting edge research; 5) opportunities
to consult, collaborate, and build mentoring relationships with Program Faculty genomic experts from multiple
institutions and specialties. All materials from the one-week course will be recorded and made freely available
online for access to any interested researcher.
A central goal of the program is to help increase diversity in the biomedical workforce. We will plan a vigorous
outreach effort with our well-established network of outreach partners to attract diverse participants. Our very
diverse Program Faculty will aid in our diversity outreach and effective mentoring efforts. In addition, we plan to
offer a series of Diversity Scholarships to attract participants from groups under-represented in the sciences. We
will also offer diversity scholarships to host faculty from minority-serving institutions, to form partnerships and to
assist them in putting our tutorials and educational tools to use in their home institutions.

Public health relevance
NARRATIVE High-throughput technology and electronic health records (EHRs) have dramatically increased the amount of data that can used for better understanding and new treatments of disease. However, analyzing the data generated by these technologies requires significant quantitative and computational expertise. Our goal is to develop a program to train current and upcoming generations of diverse biomedical researchers in the skills needed to fully mine the potential of the large amount of available data, and put it to use in furthering diagnosis and treatment of disease, and promoting public health.